Emory Vaccine and Treatment Evaluation Unit - DMID 21-0002

Summary/Abstract The Emory VTEU has proven essential in the fight against the pandemic. This supplement will allow for further investigations into vaccines trials (21-0002). 1

Public health relevance
Narrative The Emory VTEU will participate in DMID 21-0002, a phase 1, open-label, randomized study of the safety and immunogenicity of a SARS-CoV-2 variant vaccine (mRNA-1273.351) in naïve and previously vaccinated adults 1